Digital Phenotyping To Screen For Early Childhood Internalizing Disorders

ABSTRACT
Childhood anxiety and depression are common, impairing, and have the potential to disrupt development well
into adulthood. Pediatricians need mental health screening tools to meet the prevalence of these internalizing
disorders early in childhood. We have developed a promising digital health approach for detecting movement
and speech phenotypes of internalizing disorders in young children. My long-term goal is to create a novel
technology for screening young children for internalizing disorders at scale. My short term objective is to
leverage my original approach and my proposed training curriculum to create a prototype mobile health
(mHealth) application that provides a composite digital phenotype to detect childhood internalizing disorders.
My specific aims are to (1) evaluate the validity of digital phenotypes measured by a novel mHealth system for
identifying internalizing disorders in young children and (2) develop a composite digital phenotype for
childhood internalizing disorders involving multiple constructs from the Research Domain Criteria (RDoC) and
identify moderating RDoC construct variables. If successful, these mHealth enabled digital phenotypes may be
used to further NIMH health initiatives of enabling better tracking of changes in internalizing mental health
status across childhood and supporting new and innovative research-practice partnerships with pediatrics to
improve dissemination of evidence-based mental health screening. Similarly, this approach answers a need
identified by the American Academic of Pediatrics for new tools that screen for behavioral and emotional
problems. Seventy children between the ages of 4 and 8 years, oversampled for internalizing disorders, will be
recruited for this study from pediatric and childhood mental health services at a university-based regional
medical center that services the state of Vermont and upstate New York. They will be administered mood
induction tasks design to press for RDoC Negative and Positive Valence constructs, while instrumented with a
belt-worn smartphone enabled with the prototype mHealth application. A composite digital phenotype will be
developed across constructs based on statistical classification models trained using machine learning on data
captured during the tasks. To carry out this work as an independent investigator, I propose an intensive training
curriculum to gain foundational skills in digital phenotyping. It includes training in (1) developmental
epidemiology to better research early childhood psychopathology through a public health lens, and (2a) mobile
app development to communicate effectively with app developers (2b) analysis of complex systems including
machine learning approaches, (2c) ethical and societal issues regarding digital psychiatry. Completion of these
training and research aims will provide me the skills and evidence to develop an easily administered digital
health technology for identifying young children with internalizing disorders in the short-term, and in the long term, the ability to successfully contribute to the emerging field of digital health for the purpose of improving
childhood mental health.

Public health relevance
This proposed project will advance a brief, feasible digital health approach to detect anxiety and depressive disorders in young children using wearable sensors. If successful, this approach has the potential to identify young children who are suffering with mental illness. The proposed training plan will allow this applicant to contribute significantly to the emerging field of digital psychiatry as an independent investigator as a long-term career.